Virtual Patient Cohorts to Illuminate Immunologic Drivers of Influenza Severity

Project Summary
Influenza viruses result in a significant number of illnesses and deaths each year highlighting its health and
economic burden. Management of this disease is difficult, and little is known about how different host factor
contribute to heterogenous outcomes. To advance the goals of understanding the diverse immune responses to
influenza and predict risk, it is essential to develop new tools that can define individualized immune trajectories,
simultaneously account for multiple sources of heterogeneity, and accurately predict dynamics that drive disease
progression. This project addresses gaps in identifying the impact that host factors have disease outcome and
gaps in developing computational methods for respiratory infections that accurately predict inflammation and
disease severity. The studies will develop and exploit new predictive systemic immune models and simulate
human populations using virtual patient cohorts aims at differentiating clinical outcomes and identify downstream
effects of varying levels of basal immunity.

Public health relevance
Project Narrative The highly pathogenic influenza viruses pose considerable public health threats with high morbidity and mortality. Infections can range from asymptomatic to deadly with varying host and viral factors associated with heterogenous outcomes. The objective of the proposed research is to develop and validate quantitative computational models and virtual patient cohorts that identify immunologic drivers of severity, biomarkers that define inflammation and distinct outcomes, and determine how distinct levels of basal immunity impact facilitate patient outcomes.